Alpha2 adrenergic signaling in AD pathogenesis

Sporadic Alzheimer’s disease (AD) likely involves multiple genetic and environmental risk factors that lead to amyloid β (Aβ) dyshomeostasis. We have recently identified the α2A adrenergic receptor (α2AAR) as a novel factor that promotes amyloidogenic processing of the amyloid precursor protein (APP) and Aβ generation through G protein signaling in neurons. Activation of α2AAR disrupts APP interaction with SorLA, a neuronal sorting receptor that has recently emerged as a risk factor for sporadic AD. Genetic deficiency and pharmacological blockade of α2AAR lead to reduced Aβ generation and improved AD-related neuropathology. Furthermore, our unpublished data using both cultured cells and animal models suggest that Aβ42 allosterically modulates α2AAR to enhance α2AAR activity. Collectively, our data suggest a novel positive feedback relationship between α2AAR activation and Aβ generation, which would exacerbate AD-related pathophysiology. Significantly, we have collected initial human evidence supporting the involvement of α2AAR in AD. First, our initial analysis of postmortem brains reveals a trend of increased α2AAR activity in AD cases. Secondly, our biostatistical analysis of the National Alzheimer’s Coordinating Center (NACC) database suggests that chronic activation of α2AR exacerbates disease progression in AD patients. Collectively, our data strongly support that α2AAR represents a previously unappreciated pathogenic factor and therapeutic target for AD. The primary objective of this proposal is to test the central hypothesis that α2AAR activation and Aβ generation form a positive feedback loop to exacerbate AD-associated pathophysiology, and that blocking this feedback loop slows AD progression. We will 1) address the mechanism of how α2AAR signaling regulates SorLA-dependent APP processing; 2) uncover the association between α2AAR activity and Aβ progression in AD; 3) determine the efficacy of α2AAR blockers in reducing pathological and cognitive deficits in preclinical AD models in which Aβ pathology is developed. Noradrenergic degeneration is a frequently observed phenomenon in AD. However, the potential role of the noradrenergic dysfunction in driving pathogenesis in sporadic AD has not been adequately addressed. We will integrate the use of human biosamples with cell-based and animal models to reveal the mechanistic contribution of an essential noradrenergic component, α2AAR, to AD pathogenesis. Our studies could lead to development of new therapeutic strategies for AD treatment.

Public health relevance
Alzheimer's disease (AD) is the major cause of devastating late-life dementia and currently there are no effective treatments to stop its progression. In this project, we seek to uncover the role of the brain α2 adrenaline receptor in driving AD-associated pathophysiology and to explore the therapeutic potential of its blockers in AD treatment. If successful, this study would advance our fundamental understanding of the etiology of this multifactorial disorder and lead to a new direction for its treatment.